Specific Pathogen Free Baboon Research Resource (SPFBRR) - A&R Administrative Supplement

Project Summary The Specific Pathogen Free Baboon Research Resource (SPFBRR) is the only national research resource of SPF18 baboons available to NIH grantees; intramural research programs of federal agencies, including the FDA, NSF and NIH; and other sponsors of biomedical research (private foundations, pharmaceutical companies, and contract research organizations). Absolutely unique in the world, the olive baboons (Papio anubis) in the SPFBRR have an extensive bioexclusion list of 18 pathogens normally found in wild and captive baboon colonies. In fact, baboons from the SPFBRR are free of all known adventitious viruses that commonly infect wild and captive baboons. A major challenge during the first few years following relocation of the colony to the Keeling Center has been developing the extensive repertoire of serology and PCR testing assays and strategies to ensure that the SPF18 animals remain free of excluded pathogens. This A&R Administrative Supplement will allow us to purchase two pieces of equipment: a Bio-Plex 200 System to develop inhouse baboon specific multiplexed serology assays, and a QX200 ddPCR System elucidate the pathogenesis of incipient virus infections in naïve olive baboons. This request directly addresses Specific Aim 2 of the P40 Resource Core to expand the breeding resource and Specific Aim 1 of the Research Core to develop molecular diagnostic assays to support the SPFBRR. The proposed study is within the scope of the parent award and will stimulate additional activities leading to the progress of the overall goals of the parent award. The proposed study does not overlap with already funded work in the parent award.

Public health relevance
Project Narrative Adventitious virus free olive baboons (Papio anubis) are a unique and invaluable resource to NIH researchers. Maintaining and improving the SPF18 Baboon Research Resource requires a greater understanding of the pathogenesis of excluded viruses and baboon specific serology reagents that are sensitive and specific to improve virus testing. The proposed project aims to purchase two pieces of equipment, a Bio-Plex 200 Luminex system to develop baboon specific serology reagents and a QX200 Droplet Digital PCR system to better understand the pathogenesis of incipient virus infections in naïve baboons.